Gene Selection for Newborn Sequencing Studies

PROJECT SUMMARY/ABSTRACT
The decreasing cost and increasing robustness of genomic sequencing technologies offer an exceptional
opportunity to advance the future of newborn screening (NBS) and increase the number of babies who have
access to lifesaving interventions. Newborn sequencing, however, comes with many ethical, legal, and social
implications (ELSI). A key determinant of benefits and risks of public health newborn sequencing, at both
individual and societal levels, is which genes are screened. The proposed study addresses this
fundamental question: how should public health NBS programs decide which genes to screen? In the
next few years, around a dozen groundbreaking research studies will conduct population-based newborn
sequencing pilot studies. Existing sequencing studies provide a time-sensitive opportunity to obtain critical
input from experts, yet it is also vital to consider viewpoints of other professional and community partners
with a stake in newborn sequencing. Understanding community preferences helps protect against missteps
in the implementation of newborn sequencing that could lead to mistrust and decreased uptake of NBS,
which is the most equitable and successful public health initiative in the United States. The first aim of this
project is to appraise and contrast approaches and criteria used by experts conducting newborn
sequencing studies to determine which genes to screen. This aim will synthesize decision frameworks,
key criteria (e.g., actionability, age of onset, penetrance), values (e.g., equity, access), and lessons learned
by newborn sequencing researchers in their experience building gene panels. The second aim is to
determine preferences and values of professional and community partners about decision-making
for genes to include in newborn sequencing. Informed by a deliberative public health approach, we will
conduct engagement with 10 panels of engagement partners that include professionals, parents, and
individuals living with genetic disorders to explore preferences and values about gene selection criteria and
associated ELSI. The project outcome is guidance that is informed by a view of common interest on how to
select genes to include in public health newborn sequencing. We will leverage expert investigator experience
at a time of high research concentration, while also closing a critical gap in ensuring integration of public,
parent, patient, and professional preferences. Rather than developing a consensus gene list (which would
require constant updating), the guidance will provide collectively defined decision-making values, gene
selection criteria, and critical ELSI while characterizing areas without broad agreement for future study. The
output of this study will guide ethical and appropriate decision-making as we prepare for future
implementation of sequencing in public health NBS.

Public health relevance
PROJECT NARRATIVE To add genomic sequencing into public health newborn screening (NBS) in a way that maximizes benefits (e.g., access to life-saving treatments) and minimizes harm (e.g., treating healthy babies unnecessarily), NBS needs a way to determine for which genes babies should be screened. This project will use the experience of newborn sequencing researchers in combination with the public, parents, patients, and health professionals to identify gene selection criteria to guide ethical and appropriate decision-making on how to select genes to screen. The resulting gene selection criteria will reflect diverse perspectives and provide NBS with much needed guidance.